Evaluating the Effect of E-cigarette Policies on Youth Tobacco Use

Abstract
Christian Saenz is currently a PhD student in Economics at Georgia State University and will have a major role
in this administrative supplement. Christian aspires to become an independent health economist and addiction
researcher. Saenz will receive detailed training in career development and in conducting tobacco policy and
addiction research as part of this supplement. The parent grant’s aims are as follows: (1) estimate the effect of
flavor bans with varying levels of strength on youth e-cigarette use, combustible tobacco product use, and
substitution towards the remaining legally available flavored tobacco products; (2) estimate the effect of
Tobacco-21 laws on youth e-cigarette use, combustible tobacco product use, and source of e-cigarettes; and
(3) estimate the effect of e-cigarette taxes, including new e-cigarette tax schema of sales taxes and two-tier
taxes, on youth e-cigarette use and CTP use. This proposed administrative supplement will complement the
parent grant’s aims by exploring how e-cigarette tax responsiveness is impacted by out-of-state and Indian
reservation purchasing, by identifying specific components of Tobacco-21 laws that make them more effective,
and by identifying the effect of e-cigarette introduction in 2006 on short- and medium-term smoking-attributable
mortality. The research proposal will leverage high quality survey data, restricted-use mortality data, and
proprietary Nielsen Homescan and Retail Scanner panel data, to study these questions. This research is
significant because it will provide insight into the economic substitution or complement relationship between
e-cigarettes and relatively more dangerous combustible tobacco; estimate heterogeneity in effectiveness of
state T21 legislation based on the strength or ‘bite’ of three specific components of the bundled legislation,
identify the elements of optimal T21 regulation; determine how tax avoidance behaviors affect e-cigarette tax
responsiveness; and estimate short- and medium-term smoking-attributable mortality effects of the e-cigarette
entry in the U.S. market in 2006. This research, if funded, would be innovative by using recent innovations on
the differences-in-differences model designed to mitigate bias from heterogeneous treatment effects and
endogeneity bias such as Callaway and Sant’Anna estimators and event study designs; by answering novel
research questions using proprietary data, and estimating state policy heterogeneity in order to inform future
legislative efforts.

Public health relevance
Project Narrative This administrative supplement is relevant to public health by supporting a PhD student’s research into how Tobacco-21 laws work, how e-cigarette taxes are avoided, and how mortality patterns have changed since the introduction of e-cigarettes. Thus, the proposed research is relevant to the part of NIH’s mission pertaining to the development of fundamental knowledge used by the United States to prevent diseases caused by tobacco use.